Expanding "Safe Spaces 4 Sexual Health," a Mobile Van HIV/STI Testing and Care Linkage Strategy, for Black MSM in online spaces

Project Summary
Ending the HIV epidemic (EHE) depends on developing innovative, strategic and tailored approaches to HIV
diagnosis, treatment and prevention. While new HIV diagnoses have declined significantly from their peak,
progress has stalled, particularly among Black men who have sex with men (MSM) who remain
disproportionately affected in the US. In the pilot study, Safe Spaces 4 Sexual Health (SS4SH), we
demonstrated the feasibility and acceptability of a status-neutral HIV/STI testing approach which identified at-
risk MSM in online spaces and linked them to testing services on a mobile van in Baltimore, MD. Focusing on
reaching MSM in online spaces who may be missed by traditional seek-test-treat strategies, our pilot reached
151 MSM over 14 months and demonstrated a significantly higher new HIV diagnosis (7% vs. 0.5%, p<0.001)
and syphilis positivity rate (10% vs. 0.5%, p<0.001) compared to the standard of care health department (HD
SOC) mobile van strategy. SS4SH pilot did not evaluate participants’ linkage to PrEP or HIV care, which are
key pillars of the EHE strategy. The objective of this proposed R21 is to expand the pilot study to integrate
PrEP and HIV care linkage, evaluate the acceptability and feasibility of this expanded strategy and in a quasi-
experimental design, generate preliminary data on the effectiveness of this strategy compared to the HD SOC
mobile van. The specific aims are: 1) Using a community-based participatory approach, expand SS4SH to
incorporate linkage to PrEP for Black MSM at high risk for HIV acquisition and linkage to HIV care for those
living with undiagnosed/unsuppressed HIV, and 2) Using a quasi-experimental design, pilot the expanded
SS4SH testing plus care linkage strategy to (1) evaluate the acceptability and feasibility of adding care linkage
and (2) generate preliminary data on effectiveness of the expanded SS4SH compared to the HD SOC mobile
van as defined by reach, reproducibility of testing outcomes, and care linkage outcome measures. Aim 1 will
involve qualitative formative work including focus groups and in-depth interviews with Black MSM and key
informant interviews with care linkage stakeholders to explore environmental and patient level barriers to care
linkage and develop community engaged linkage strategies to overcome these barriers. A community advisory
board (CAB), composed of Black MSM recruited from focus group and interview participants will provide
member-checking of the study team’s interpretations of qualitative data and partner with the study team to
develop the expansion of SS4SH for care linkage to be implemented during the Aim 2 pilot. In Aim 2, we will
recruit MSM (ages 18-49) for mobile van HIV/STI testing/care linkage over 8 months. We will evaluate outcome
measures of feasibility and acceptability of providing care linkage and generate preliminary data on the
effectiveness of the SS4SH compared to the HD SOC mobile van strategy. The proposed research has the
potential to inform public health strategies prioritizing Black MSM and potentially reduce ongoing HIV
disparities by reaching both those at risk for acquisition and transmission and linking them to care.

Public health relevance
Project Narrative The proposed project seeks to expand and pilot a status neutral online-linked mobile HIV/STI testing and care linkage strategy for Black gay, bisexual and other men who have sex with men (MSM) at high risk for HIV acquisition or transmission. This project is relevant to public health because Black MSM are disproportionately impacted by the HIV epidemic, but rates of HIV testing, care linkage to HIV pre-exposure prophylaxis (PrEP) and treatment remain disproportionately low in this priority population. Our proposal aligns with the goals of the Ending the HIV Epidemic federal initiative by developing an innovative, strategic and tailored approach to effective HIV diagnosis, treatment and prevention for high risk Black MSM and has the potential to inform public health strategies prioritizing Black MSM by reaching both those at high risk for acquisition and transmission.